Comparing End-of-Life Home Health and Hospice Use in Medicare Advantage vs. Traditional Medicare among Decedents with Dementia

PROJECT SUMMARY/ABSTRACT
Medicare Advantage (MA) plans increasingly shape the care of older adults with functional disability, and in
particular those with advanced Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD).
Indeed, in 2021, 42% of Medicare beneficiaries are enrolled in MA plans. However, we know little about quality
of care delivery and outcomes within the MA program. MA is unique from traditional Medicare in that a private
health company is paid a set rate by Medicare, and then can offer more flexible benefits and cost-sharing to
enrollees, albeit also employing structures such as limited provider networks and prior authorization
requirements for treatments to control costs. Preliminary research, including that done during my K76 Paul B.
Beeson Emerging Leaders Career Development Award in Aging, has found that older adults are more likely to
leave MA for traditional Medicare after the onset of functional disability, and the family and friends of decedents
in MA plans report lower quality of end-of-life care. This raises the question of how MA plans are delivering
services that are important to community-dwelling older adults with advanced AD/ADRD, such as home health
and hospice. My prior work has found that older adults with AD/ADRD not only rely on high levels of these
services, but use home health differently than their counterparts without AD/ADRD. It is unclear how
enrollment in MA shapes these use patterns, although pilot data within the National Health and Aging Trends
Study indicates that decedents with AD/ADRD in MA plans may receive less home health than their
counterparts in traditional Medicare. Not only is it uncertain if this is true in a larger cohort, but also is it
unknown how differences between MA plans, such as the plan type and the degree to which older adults with
AD/ADRD are enrolled in the plan, shapes home health and hospice use. This Alzheimer’s-focused
administrative supplement will allow me to expand my current work, supported by the K76 Paul Beeson
Emerging Leaders Career Development Award in Aging, in order to gain the scientific skills to develop as an
AD/ADRD researcher working to improve Medicare delivery while addressing the following specific aims: in
SA1, I will compare patterns of home health and hospice use in the last year of life between decedents with
AD/ADRD in MA vs. traditional Medicare; in SA2, I will assess if MA plan type and the concentration of older
adults with AD/ADRD within the MA plan influences patterns of home health and hospice use in the last year of
life. This 1-year project will fill a scientific gap in our understanding of the role of MA plans in shaping the care
of older adults with AD/ADRD in the last year of life. It will provide preliminary data that will inform my planned
R01 proposal examining further patient outcomes and drivers of high-quality care at the end of life in MA plans,
with a focus on decedents with AD/ADRD. Given the growing influence of MA on older adults with AD/ADRD
as well as our broad need to understand how to best support this population as they age in the community, this
proposed supplement is timely to improve care for older adults with AD/ADRD.

Public health relevance
PROJECT NARRATIVE This research will use innovative methods employing Medicare claims to examine the end-of-life care patterns of older adults with Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD) in Medicare Advantage (MA) vs. traditional Medicare. This project will examine services that are critical to aging in place, home health and hospice, and then assess how MA plan structures shape services. Given that 42% of older adults are insured by MA plans but little is known about quality of care in these plans, this project will provide insight to improve the care of older adults with AD/ADRD.